Causes and consequences of virulence factor attenuation in Mycoplasma pneumoniae biofilms

How the human pathogen Mycoplasma pneumoniae attenuates virulence factor production during growth as
biofilm towers, and how this attenuation favors chronic respiratory disease, including both pneumonia and
asthma, are unknown. Our long-term goal is to understand the processes that are essential for establishing and
maintaining M. pneumoniae infection. The overall objective of this application is to understand how M. pneu-
moniae biofilm towers chronically infect respiratory epithelial host cells at an air-liquid interface (ALI). Our
central hypothesis is that the reduction in virulence factor production by M. pneumoniae bacteria in biofilm
towers is signaled by decreased O2 levels and results in minimization of both defensive responses and damage to
the epithelium. The rationale underlying these experiments is that once the extent to which damage is limited
by changes to M. pneumoniae during biofilm tower growth and maintenance is understood, approaches that
counter the scheme of limiting host responses could be developed as therapeutic agents to reduce morbidity
associated with chronic M. pneumoniae infection. We plan to test our central hypothesis by pursuing the follow-
ing two specific aims: 1) characterize the development and impact of M. pneumoniae biofilms in a respiratory
epithelial air-liquid interface tissue culture model; and 2) determine the role of O2 in regulating M. pneumoniae
gene expression and steady-state levels of virulence-associated proteins in vitro. For the first aim, we will char-
acterize the impact of M. pneumoniae biofilm towers on airway epithelia in an ALI tissue culture model using
microscopy, transcriptomics of the host cells, and measurements of epithelial barrier function like transepithelial
electrical resistance, ciliation, and localization of the ZO-1 tight junction protein, comparing these effects to those
produced by CARDS toxin and H2O2, toxic molecules whose production is attenuated in M. pneumoniae during
biofilm tower growth. For the second aim, prompted by preliminary data about the decreased activity of the
H2O2-producing enzyme glycerol 3-phosphate oxidase in M. pneumoniae grown in low O2, we will investigate
the bacterial response to growth in 10% O2 at the levels of transcription a global level, and, for select virulence-
associated proteins, steady-state abundance. The proposed research is innovative, in our opinion, because it
represents a substantive departure from the status quo by focusing on how M. pneumoniae both responds to and
impacts its environment within a biofilm context, using biofilm tower growth in an ALI airway epithelial model
and studying gene regulation in a biofilm environment. This contribution will be significant because it is expected
to direct future research efforts toward development of therapeutic intervention strategies targeting M. pneu-
moniae biofilms. Additionally, the work in this AREA proposal will provide training in fundamental microbio-
logical, transcriptomic, and tissue culture techniques for 4-5 undergraduate and a graduate student with career
interests in particular areas of biomedical research, with a significant effort to include underrepresented minor-
ities.

Public health relevance
The proposed research is relevant to public health because current antibiotic therapy is poor at preventing chronic, long-term infection by the pathogen Mycoplasma pneumoniae. A deep understanding of M. pneumoniae biofilms, which are masses of bacteria that resist current drugs, is required to more effectively reduce disease caused by this common pathogen, including asthma and autoimmune diseases that result from chronic infection. This project is directly relevant to NIH’s mission in that part of the stated mission of NIH is to “foster fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately protecting and improving health.”